EFFECT OF HUMAN GROWTH HORMONE ON NITROGEN BALANCE IN CATABOLISM

This study compares the effects of growth hormone on protein and mineral balance, body composition and bowel absorption in patients with gastrointestinal tract dysfunction. The first study week serves as a control period and thereafter growth hormone is administered at a dose of 0.41mg/kg body weight. Each patient serves as his/her own control.